DEPRENYL AND TOCOPHEROL ANTIOXIDATIVE THERAPY OF PARKINSONISM

This study continues to examine the effectiveness and safety of deprenyl and tocopherol (vitamin E) in patients who are in the early stages of Parkinson's Disease.